Valuation Mechanisms that Shape the Interaction of Phasic and Tonic Dopamine

PROJECT SUMMARY
Dopamine (DA) is a critical neuromodulator for mood, motivation, and reward-based learning. Dysregulated DA
dynamics across brain regions and timescales contribute to psychiatric and substance use disorders, yet how
DA timescales mediate the relationship between learning and motivation remains unresolved. Striatal DA
release is documented to fluctuate on fast “phasic” and slower “tonic” timescales, hypothesized to regulate
learning and motivation, respectively. Prevailing reinforcement learning (RL) theories suggest that phasic DA
transients encode reward prediction errors (RPEs), which diffuse and accumulate into tonic DA levels to
regulate motivational engagement. This interpretation assumes that subjective values driving motivational
engagement are reactive to recent reward exposure. However, alternative theories propose that tonic DA may
arise independently from phasic DA, reflecting proactive effort allocation based on internal calculations rather
than recent reward exposure. Resolving these conflicting views is essential for understanding DA’s role in
motivation and its dysfunction in psychopathology. This proposal aims to define the circuit and computational
mechanisms linking phasic and tonic DA to flexible motivational engagement. Using a novel broadband DA
measurement technique we recently developed, I will analyze how DA dynamics across timescales interact to
support reactive-vs-proactive motivational flexibility. Aim 1 will assess how these valuation processes influence
the relationship between phasic and tonic DA. Aim 2 will identify circuit mechanisms regulating how phasic DA
signals accumulate into tonic levels under varying task demands of reactive-vs-proactive value learning. These
studies will reconcile longstanding theoretical debates on DA function, providing a mechanistic and
computational framework for understanding how DA shapes motivation and learning across timescales. The
insights gained from these experiments will inform targeted interventions for circuit-specific vulnerabilities in
addiction, depression, and psychosis.

Public health relevance
PROJECT NARRATIVE Disordered motivation and learning in psychiatric and substance use disorders stem from a breakdown of dopamine regulation across brain regions and timescales. This research aims to characterize the precise behavioral conditions and circuit mechanisms that facilitate multi-timescale dopamine interactions in service of motivational flexibility. This proposal seeks to characterize the subjective valuation processes and circuitry governing multi-timescale dopamine release, aiming to identify distinct mechanisms selectively vulnerable in addiction and psychiatric disorders.